Hox Gene Regulation of Skeletal Repair

PROJECT SUMMARY/ABSTRACT
Hox genes are a group of evolutionarily conserved transcription factors important for several developmental
processes, including patterning of the anterior-posterior axis of the skeleton. The Hox11 paralogous gene
group, which is expressed in the zeugopod region (radius/ulna and fibula/tibia), are necessary for proper
patterning of the zeugopod. In the past few years, work from the Wellik laboratory has shown that these
developmentally important Hox transcription factors remain expressed in the skeleton throughout life,
specifically in progenitor-enriched mesenchymal stem cells (MSCs). Rigorous genetic lineage labeling from the
lab demonstrated that these cells give rise to all three mesenchymal lineages, osteoblasts, chondrocytes and
adipocytes, and exhibit life-long self-renewal, providing strong evidence that this population of cells are skeletal
stem cells. A key question based on this information is whether Hox gene function is important in these stem
cells throughout life. We recently reported that temporal deletion of Hox11 at adult stages results in defects in
osteoblastogenesis, wherein differentiation is initiated, but osteoblasts and osteocytes fail to mature. Adult
conditional loss of Hox11 function results in a progressively weakened bone matrix where collagen does not
properly assemble in remodeling bone. In this study, I will use a temporally-controlled, conditional loss-of-
function model to assess defects in response to fracture repair (Aim 1). Preliminary data shows that
temporally-deleted, ROSACreERT2/+;Hoxa11eGFP/-;Hoxd11LoxP/LoxP mice are unable to repair after fracture.
Additionally, preliminary data suggest that the populations of osteoblasts and chondrocytes appear to be in
abnormal in mutants. Using Hoxa11CreERT2 to enact both deletion and lineage labeling, I can mark the cells that
have undergone recombination for isolation and transcriptomic analyses (Hoxa11eGFP/CreERT2;Hoxd11LoxP/LoxP;
ROSAtd-Tomato/+, Aim 2). Fracture injury induces an acute response in which stem/progenitor expansion and
differentiation to both skeletal lineages is occurring simultaneously, providing an excellent model to isolate
single cells and identify the pathways and targets Hox genes regulate in these processes. Preliminary data
shows that a large proportion of GFP+ cells are available for collection from the fracture callus, making single
cell sequencing not only possible, but a highly effective tool to investigate transcriptomic change in Hox-
expressing and Hox-lineage cells. The overall goal of this project is to define Hox genetic function in fracture
repair and to identify the molecular mechanisms by which Hox genes regulate skeletal behavior in this process.

Public health relevance
PROJECT NARRATIVE Hox gene expression has been best characterized during embryonic development, but recent work has established that Hox genes continue to be expressed throughout life in the skeleton in progenitor-enriched MSCs. Genetic lineage labeling has demonstrated contribution to bone, cartilage and bone marrow adipose cells as well as self-renewal of this population throughout life, establishing them as skeletal stem cell population. Hox11 genes continue to play a role in skeletal homeostasis, but their roles in repair and regeneration of the skeleton in response to fracture has not been reported and this proposal aims to dissect the genetic roles of Hox11 genes in fracture repair and use single cell sequencing of Hox-expressing and Hox- lineage cells to interrogate the molecular mechanisms by which Hox genes regulate repair.